Therapeutic insights through patient derived leukemia xenografts

Abstract
Genetic mouse models have been a powerful system to delineate key mechanisms of cancer
development. However, there are likely to be gene expression and regulation differences
between mouse and man that affect the applicability of some findings in these models.
Furthermore, the inbred strains that are used may come with additional genetic caveats due to
loss of heterozygosity. For these and other reasons, many cancer studies that identify targets or
mechanisms in mouse systems benefit from replicating key findings in a relevant human cell
model. Indeed, this has become a common expectation for high impact studies. Human
pediatric leukemia is genetically diverse with many potential combinations of driver and
accessory mutations, each potentially affecting phenotype. Therefore, a large bank of xenograft
models is required to replicate the heterogenous nature of the disease as found in patients.
Xenograft technology continues to advance rapidly. There has been a steady proliferation of
immunodeficient mouse strains, each with specific strengths relative to each other. More
sophisticated in vivo studies are now possible because of these new strains and many other
technical advances in sample processing, detection, analysis, and modeling of therapeutic
interventions. However, these mice are difficult to breed and manipulate due to their
immunodeficient status. Human cells also require a different set of considerations. Human
hematopoiesis in this environment is very different from what is found in mouse transplant
systems. There are additional host versus graft and graft versus host issues to consider. Human
cells require different culture conditions and transduction protocols. Human cells are
morphologically distinct. The markers used for detection are very different, making flow
cytometry experiments much more involved. I have spent the last 19 years working with these
models and have made continuous improvements along the way. I have a well-documented
history of developing new innovative methods and models for the leukemia research
community. My ability to apply my unique experiences to the projects of many NCI funded
investigators through the set of xenograft resources that I have built adds significant efficiency
and value to the science that can be done at our institution. This proposal is aligned with NCI
initiatives to use mouse models and genomics to identify new molecular mechanisms of
carcinogenesis, delineate mechanisms of resistance, and identify new targets for drug discovery
and development.

Public health relevance
Project Narrative There are significant hurdles in the way of investigators wishing to employ xenograft models of various hematopoietic cancers. In addition to the lack of sufficient numbers of robust, readily available xenograft models such as PDX, numerous technical challenges must be overcome to successfully perform xenograft experiments. Based on my extensive experience in the field, I have built a comprehensive resource, the Humanized Mouse Resource, to address these issues that is tailored to meet the needs of internal and external collaborators, particularly those with NCI funded projects.